Cholestatic Liver Injury

PROJECT SUMMARY
The overall objective is to define the cellular mechanisms that contribute to cholestatic liver injury. The ductular
reactive (DR) cell population arising in cholestatic liver injury promotes hepatic fibrosis. Our proposal is
focused on DR cell apoptosis as a potential therapeutic strategy to attenuate cholestatic liver injury and
fibrosis. To this end, we have made several pivotal observations. We observed that tumor necrosis factor-
related apoptosis-inducing ligand (TRAIL) receptor (TR), a death receptor, limits the extent of the DR cell
population in vivo in a murine model of cholestasis (Mdr2-/- mice) by inducing DR cell apoptosis. This
observation indicates that DR cells may be considered “primed” for apoptosis. As macrophages express
TRAIL, we next examined if DR cells by a compensatory counter regulatory process may promote macrophage
TRAIL expression thereby limiting their expansion. EpCAM positive reactive cholangiocyte (ERC) organoids
from Mdr2-/- mice were developed by us as a DR cell model. ERC organoids release extracellular vesicles
(EVs) which contain cargo promoting macrophage TRAIL expression. Specifically, the EVs contain S100A11, a
damage-associated molecular pattern (DAMP) protein, which binds scavenger receptors (SR) on
macrophages. Accordingly, an inhibitor of the SR termed Mer receptor tyrosine kinase (MerTK) attenuated
TRAIL-induction in macrophages by the EVs. Cells primed for TRAIL cytotoxicity are sensitive to BH3 mimetics
targeting myeloid cell leukemia 1 (Mcl1), a pro-survival member of the Bcl-2 protein family. Consistently, ERC
organoids underwent apoptosis by a BH3 mimetic targeting Mcl1, S63845. Based on these preliminary data,
we formulated the CENTRAL HYPOTHESIS that DR cells promote a compensatory counter regulatory
process to limit their expansion by inducing macrophage TRAIL expression, and are primed for cell
death which can be exploited therapeutically to attenuate cholestatic liver injury. We will now employ
current and complementary experimental approaches, and preclinical models to examine this hypothesis. Our
SPECIFIC AIMS will test three hypotheses. FIRST, we will test the hypothesis that TRAIL/TRAIL receptor
signaling, using conditional knockout mice, directly restrains the DR cell population in cholestasis by
mechanisms dependent upon: a) TRAIL receptor expression by DR cells; and b) TRAIL expression by
macrophages. SECOND, we will test the hypothesis that ERC organoids release EVs inducing TRAIL
expression in macrophages by mechanisms dependent upon: a) the EV cargo S100A11; and b) MerTK
activation on macrophages. FINALLY, we will test the hypothesis that ERC organoids and DR cells are primed
for cell death such that: a) survival is dependent upon the anti-apoptotic function of Mcl1 in vitro; and b)
pharmacologic targeting of Mcl1 in vivo induces DR cell apoptosis thereby attenuating liver injury and fibrosis.
This technically and conceptually innovative application, is also significant because it may identify
therapeutic strategies for purposefully inducing DR cell apoptosis to limit cholestatic liver and fibrosis.

Public health relevance
PROJECT NARRATIVE This application examines the mechanisms by which a reactive liver cell population termed “ductular reactive cells” promotes liver injury in disease models of impaired bile flow. We propose that ductular reactive cells are primed for cell death, and that purposefully inducing cell death of the ductular reactive cells is therapeutic for these liver diseases. The results of these preclinical studies have the potential to identify new therapeutic strategies for human liver disease characterized by impaired bile flow.